Gene Regulatory Mechanisms of the Coronary Artery Disease Gene PRDM16 on Smooth Muscle Cell Phenotypic Modulation

PROJECT SUMMARY/ABSTRACT
Despite decades of progress, coronary artery disease (CAD) remains the top global cause of death. While
hundreds of CAD-associated genes have been identified, the translation into new treatments has been
hampered by a lack of understanding of the molecular mechanisms tying these genes to disease risk. Although
smooth muscle cells (SMCs) harbor much of the attributable risk for CAD and comprise the main cellular
component of diseased vessels, no currently available treatments target these cells directly. As CAD
progresses, SMCs undergo a complex process of phenotypic modulation, where SMCs migrate, proliferate, de-
differentiate, and transition into other cellular states, including protective “fibromyocytes” (FMC).
The candidate, Dr. Brian Palmisano, has developed strong preliminary data that support the CAD-
associated gene, PR domain containing 16 (PRDM16), is a critical regulator of SMC phenotypic modulation.
PRDM16 is an epigenetic modifier involved in cell state transitions in several cell types, and is highly
expressed in vascular tissues, but its role in SMC phenotypic modulation and atherosclerosis is currently
unknown. The candidate’s preliminary data indicate that SMC-specific loss of Prdm16 in an animal model of
atherosclerosis leads to an increase in FMC development. In human coronary SMCs, overexpression of
PRDM16 regulates SMC phenotypic modulation. As an epigenetic modifier with histone methyltransferase
activity, PRDM16 also altered the enrichment of several histone methylation marks at genes related to SMC
phenotypic modulation. This led to the candidate’s central hypothesis that PRDM16 regulates SMC phenotypic
modulation and the transition to FMCs through its epigenetic modification of chromatin substrates, which will
be tested in three specific aims. Aim 1 will determine the regulatory mechanisms by which PRDM16
suppresses SMC phenotypic modulation in vitro. Aim 2 will determine the gene regulatory networks underlying
Prdm16-mediated phenotypic modulation of SMCs in vivo. Aim 3 will determine the downstream factors
governing PRDM16-mediated phenotypic modulation of SMCs in vitro.
The enclosed training plan encompasses research, mentoring and career development activities that have
been specifically formulated to develop the scientific and professional skills necessary for Dr. Palmisano to
transition to an independent physician scientist studying novel molecular mechanisms of atherosclerosis. Dr.
Palmisano will develop his skills in bioinformatic integration of multi-omic datasets and smooth muscle cell
function under the mentorship of his primary mentor, Dr. Tom Quertermous, co-mentor, Dr. Josh Knowles and
his expert advisory committee, each with expertise in multi-omic data analysis and mentorship of physician
scientists. Collectively, these studies will identify the molecular mechanisms by which the CAD-associated
gene PRDM16 regulates SMC phenotypic modulation, a critical process related to CAD disease risk, allowing
Dr. Palmisano to launch his independent career as a physician scientist.

Public health relevance
PROJECT NARRATIVE Much of the attributable risk of coronary artery disease (CAD) lies in smooth muscle cells, which undergo a complex process of “phenotypic modulation” whereby cells migrate, de-differentiate, and proliferate over the course of disease. The molecular mechanisms of how CAD-associated genes affect this phenotypic modulation remain poorly understood. This proposal will determine how the CAD-associated gene PR domain containing 16 (PRDM16) regulates phenotypic modulation, paving the way for new targets to treat CAD, the world’s leading cause of death.